Training Program in the Neurobiology of Cognition and Cognitive Disorders

Abstract
This is the second competitive renewal application for the Training Program in Neurobiology of
Cognition and Cognitive Disorders at the University of Alabama at Birmingham (C&CD Program). The
C&CD Program is housed in the Department of Neurobiology, and includes 43 faculty from 15 basic
science and clinical departments in the School of Medicine (SOM), School of Optometry, and College of
Arts and Sciences. The success of the C&CD Program in its recent funding period is evidenced by its
robust participation (34 total students), graduation of a talented cadre of doctoral students (25 PhDs
graduated-5 URMs), with an average of more than four publications each, and all transitioning to
competitive postdoctoral positions or completing clinical training. The overall goal of the C&CD Program is
to create the next generation of talented, diverse and independent scholars and leaders in cognitive
neurobiology. These responsible individuals will have (1) a solid foundation in molecular, cellular and
cognitive neuroscience theories and findings, (2) training in the mechanisms for translating basic research
into advancements in the treatment of cognitive disorders, and (3) be well-prepared to employ a
multidisciplinary research approach using skill sets encompassing the next generation of tools and
technologies to address important questions in cognitive neurobiology. The specific “value added”
components of the C&CD Program include the special clinical/translational training experience in patient-
oriented research, interactions with both basic science and clinician scientist mentors, and distinct
extracurricular activities. The UAB SOM has planned expansions for the Department of Neurobiology and
Clinical Neuroscience with investments in areas relevant to cognition and cognitive disorders, thus
providing a supportive environment for the future of the C&CD Program which will benefit substantially
from this investment with the addition of dynamic new faculty mentors and research facilities.

Public health relevance
Project Narative The UAB T32 Predoctoral Training Program in Neurobiology of Cognition and Cognitive Disorders program (C&CD Program) is dedicated to training the next generation of talented, diverse and independent scholars and leaders in cognitive neurobiology. These responsible individuals from the UAB Graduate Biomedical Sciences (GBS) and UAB Medical Scientist Training (MSTP) Programs will have a solid foundation in molecular, cellular and cognitive neuroscience theories and findings, training in the mechanisms for translating basic research into advancements in the treatment of cognitive disorders, and be well-prepared to employ a multidisciplinary research approach using skill sets encompassing the next generation of tools and technologies to address important questions in cognitive neurobiology. Our objective is to build on the remarkable successes that the C&CD Program has had in the previous 10 years and provide trainees enhanced training in experimental rigor, a better understanding of true translational research and a firm grasp of how to apply the next generation tools and technologies.